AWARENESS, EDUCATION, AND TRAINING: CANCER TRIALS SUPPORT UNIT (CTSU)

The contractor will attend a Kick-off Programmatic Meeting by conference call with the Contracting Officer’s Representative (COR), Contracting Officer (CO), and other Program and Office of Acquisition Staff where the Contractor shall provide a presentation and participate in discussion of best practices and other standardized procedures that will be used under all Task Orders for the Base Statement of Work, as well as discussion of potential expansion or improvement of the CTSU program. The contractor will also submit a Meeting Summary Report that includes the Contractor’s recommendations for best practices, potential expansion, and improvement of the CTSU Program. The report shall also include a summary of the Programmatic Meeting. TO3A: The Contractor shall: work together with the Government and outgoing contractor to ensure an orderly, secure, and efficient transition of Task Order-related activities by drafting and implementing a transition plan to include potential risks and mitigation strategies. Additionally, develop materials for promotion and education of NCI trials.
- create a site initiation packet for each CTSU study
- develop training materials for selected trial roles.
- provide certified translations for selected protocol documents (e.g. informed consent document, select promotional documents) into the top 10 most frequently spoken languages in the US besides English and Spanish
- perform continuous Improvement activities to:
- increase NCI visibility and participation at national oncology meetings such as ASCO, ASH, AACR, etc.
- evaluate selected CTSU awareness, education and training, and other materials, to determine consistency, usability, and appropriateness based on subject matter and targeted audience.
- as needed, provide consultation to other NCI contractors regarding potential awareness, education, and training strategies.